Cancer Prevention & Control Research Program

CANCER PREVENTION AND CONTROL
PROGRAM CODE: CPC
PROJECT SUMMARY/ABSTRACT
The mission of the Cancer Prevention and Control (CPC) Research Program is to conduct exceptional cancer
prevention and control research in the YCC catchment area of Connecticut and beyond that informs policy,
guides clinical practice, and drives equitable care. The CPC mission is aligned with and in support of the YCC
Strategic Plan’s mission to conduct impactful research and translate findings into improved prevention and
treatment, with a focus on the cancer burdens in Connecticut.
Xiaomei Ma, PhD, and Michaela Dinan, PhD co-lead CPC. Together, X Ma and Dinan facilitate the collaboration
of CPC members with members from other Research Programs and Clinical Research Teams (CRTs) with the
goal of stimulating transdisciplinary research that will impact cancer risk and mortality rates within and beyond
the State of Connecticut. X Ma serves as a liaison with the Cancer Research Training and Education
Coordination Core (CRTEC), and Dinan is the liaison with YCC’s COE Center for Community Engagement and
Health Equity (CEHE).
There are 42 CPC members, with primary appointments in 9 departments across three schools. CPC has a
strong program-wide emphasis on health disparities research, as well as conducting impactful research in YCC
cross-cutting themes of obesity, tobacco control, and early-onset cancer. Of the four priority cancers established
in the YCC Strategic Plan, CPC members have strong programs of research that align with each of these disease
areas – breast, prostate, lung, and liver cancers. However, CPC members’ research also extends beyond these
priority cancers into many additional areas of expertise, often collaborating with other YCC research programs.
CPC is closely aligned with COE, with many CPC members playing key roles within COE, allowing for optimal
integration of the community voice and underserved populations into CPC’s research. CPC also works closely
with YCC’s Plan to Enhance Diversity (PED) Office to recruit, retain, and promote a culture of inclusivity within
CPC to advance the research and careers of women and members of groups that are under-represented in
oncology. CPC is also actively engaged with CRTEC with CPC members leading two T32 grants, mentoring
recipients of multiple F and K career development awards and leading a nationally recognized NCI R25 training
course in transdisciplinary research in energetics and cancer.
CPC members published 616 papers during this award period, 18% in high impact journals, with inter-
programmatic (29%) and intra-programmatic (25%) collaborations demonstrating interactions among CPC
members within the Program, as well as with YCC members in other Programs. Total cancer-related funding is
$10.5M (annual direct costs), including $8.4M in peer-reviewed funding, of which $2.9M is from NCI.

Public health relevance
CANCER PREVENTION AND CONTROL RESEARCH PROGRAM – NARRATIVE Not applicable.